Episodic Future Thinking in Early Childhood: Neural and Behavioral Indices of Memory and Planning

PROJECT SUMMARY/ABSTRACT
Episodic future thinking (EFT) involves sampling past experiences to generate hypothetical future outcomes
and is critical for successful planning. The primary goal of this proposed project is to better understand the
development and capacity of EFT. In Aim 1, we will quantify the processing capacity of EFT during memory
retrieval and planning, defining components of functional EFT, in 3-, and 4-year-olds and examine how
capacity changes as a function of age. We will also examine the neural correlates underlying these EFT
processes and provide a potential neural index of effort during EFT. EEG and eye tracking data will be
collected while children complete a novel episodic future thinking task. In Aim 2, we will examine the
developmental stability of early EFT using a longitudinal design. In both Aims, the proposed project will be the
first to examine (1) the capacity of memory retrieval and planning during EFT, (2) the structure of EFT
longitudinally, (3) the neural signatures of EFT in early childhood. We predict that EFT capacity will increase
with development, with larger age-related increases observed for planning than memory retrieval. We also
predict that similar neural regions (frontal and temporal) that are active during EFT in adults will be active in
children, and that neural activity (i.e., EEG power) will show more mature patterns (similar to adults) as
children age and EFT capacity increases. Finally, we predict that EFT will show stable individual differences
from 3-4-years of age, but that planning will increase at a steeper rate than memory retrieval.

Public health relevance
PROJECT NARRATIVE The proposed research aims to contribute to public health by establishing the developmental time course of the mechanisms, stability, and limits of episodic future thinking, using both behavioral and neural measures during early childhood development. Understanding the structure and capacity of typically developing episodic future thinking may allow for earlier identification for children at risk for possible cognitive and educational delays, since episodic future thinking is related to both planning and academic success. Further, such advances in prediction may allow for the development of more efficient interventions.